Children's Oncology Group NCI Community Oncology Research Program (NCORP) Research Base grant

Project Summary
The prognosis for children with cancer has improved dramatically over the past decades with an overall 5-year
survival rate now at 84%. However, the late effects of cancer treatment, including permanent organ and tissue
damage, hormonal and reproductive dysfunction and second cancers, are of special concern, with more than
40% of the estimated 360,000 survivors of childhood cancer experiencing a significant health-related quality of
life complication from childhood cancer and its treatment. In addition, progress for a number of childhood cancers
remains limited with approximately 50% of children with acute myelogenous leukemia, 50% of children with
high-risk neuroblastoma, and more than 90% of children with brainstem glioma, still succumbing to their disease.
The Children’s Oncology Group (COG), the world’s largest organization devoted exclusively to childhood and
adolescent cancer research, and its multidisciplinary research teams comprised of more than 9,000 members,
conducts research at more than 220 leading children’s hospitals, universities, and cancer centers. This proposal
is for the COG NCI Community Oncology Research Program (NCORP) Research Base to continue its
collaborative research work for our 26 community and 16 minority/underserved NCORP sites. With COG’s
significant scientific, statistical, data management and information technology infrastructure, we seek to conduct
pediatric clinical trials to define optimal treatments, and conduct laboratory research that will translate into more
effective treatments with reduced side effects. The COG directly addresses the NCORP goals of providing
access to state-of-the-art cancer treatment at community sites while conducting research in cancer control,
including post-treatment surveillance/survivorship, and cancer care delivery. We promote the participation of
community-based investigators in all of COG’s research, governance and administration and in NCORP Network
activities. The COG’s research goals are to reduce overall mortality and morbidity, decrease acute and delayed
treatment-related toxicities, and develop more effective ways of delivering care to children, adolescents and
young adults. The COG NCORP Research Base is uniquely positioned to elucidate the impact of different health
care delivery characteristics on outcomes, to identify determinants of poorer outcomes in underserved groups
including adolescents and young adults, and to develop targeted strategies aimed at eliminating disparities and
improving efficiencies for the delivery of cancer care in young persons with cancer.

Public health relevance
Project Narrative The Children’s Oncology Group (COG) is the world’s largest organization devoted exclusively to childhood and adolescent cancer research with more than 9,000 members at over 220 leading children’s hospitals, universities, and cancer centers across the U.S., Canada and other countries. The COG conducts therapeutic trials as well as cancer control and cancer care delivery research studies to improve outcomes across diverse populations including adolescents and young adults with cancer.